Lung Endothelial Aß in infectious proteinopathy

PROJECT SUMMARY/ABSTRACT
Pathogens responsible for nosocomial pneumonia elicit production of lung endothelial cell amyloids. These
amyloids can have antimicrobial properties and be beneficial to the host, or they can have cytotoxic properties
and be detrimental to the host. In the latter case, endothelial-derived amyloids may contribute to end organ
dysfunction in the aftermath of critical illness. Bacterial virulence factors, such as the Pseudomonas
aeruginosa type III secretion system effectors, and most notably exoenzyme Y, convert endothelial amyloids
from antimicrobial to cytotoxic species. Amyloid-beta (Aβ) is one of the cytotoxic amyloids generated following
endothelial infection. Aβ is released from endothelium where it becomes a transmissible and self-replicating
prion cytotoxin. Our preliminary data reveals that γ-secretase activating protein plays a critical role in
generating cytotoxic Aβ. We found γ-secretase activating protein expression in endothelial cells using non-
biased microarray, RNAseq, methylation and miRNA screens, and confirmed protein expression and function
in microvascular endothelium. γ-secretase activating protein deletion prevented formation of the cytotoxic Aβ
species. Rather, following γ-secretase activating protein deletion the Pseudomonas aeruginosa- and
exoenzyme Y-induced Aβ had antimicrobial properties. Exoenzyme Y is a promiscuous nucleotidyl cyclase that
results in protein kinase A activation, which may phosphorylate Aβ necessary to increase its cytotoxic activity.
These data suggest production of cytotoxic Aβ is due to two inter-related mechanisms, including an increase in
γ-secretase activating protein function and the phosphorylation of Aβ once it is produced. Hence, this proposal
tests the hypothesis that exoenzyme Y promotes the production of cytotoxic Aβ, dependent upon γ-secretase
activating protein.

Public health relevance
PROJECT NARRATIVE Nosocomial pneumonia represents a major cause of patient morbidity and mortality. Even after patients are released from the hospital, critically ill patients who developed infection during their hospital stay have high rates of death. In this application we investigate a mechanism of cellular injury induced by bacteria that is transmissible and self-replicating among cells in the lung, and as such, may contribute to both the short term and long term consequences of infection.